Neurovascular Contributions to Cognitive and Mental health in Older Adult Critical Care Survivors

ABSTRACT/SUMMARY:
Patients who survive an Intensive Care Unit (ICU) hospitalization will likely experience new or worsened physical,
mental, and/or cognitive impairments (termed Post-Intensive Care Syndrome (PICS)). The most vulnerable to
long-term physical and cognitive impairments are older adults (>60 y) because of pre-existing age-related
physical frailty or cognitive frailty. Both of which increase a survivor’s likelihood of developing Alzheimer’s
diseases and related dementias. However, although advances in critical care treatments have reduced mortality
rates among older adult ICU survivors, roughly 67% suffer PICS. Yet, identification of at-risk older adults during
admittance is likely difficult because of the 1) homogeneity in the clinical presentation of patients with pre-existing
age-related physical frailty and critical illness compared to those suffering from only critical illness and 2) many
patients arrive severely debilitated making administration of physical function or other volitional assessments
difficult. Therefore, it is essential that new biomarkers to guide early diagnosis, prognosis, and disease
monitoring are identified. To this point, tryptophan derivatives, particularly kynurenines and nicotinamide family
(e.g., NAD+), have been shown to mediate the relationship between chronic inflammation and physical
impairment or signal accelerated aging, respectively. However, it remains unknown if similar associations exist
in older adult ICU patients and the prognostic utility of elevated neurotoxic tryptophan metabolites relative to
neuroprotective tryptophan metabolites to predict adverse health outcomes while in the ICU. Thus, to fill this
knowledge gap I have design three studies to explore the associations between tryptophan derivatives,
musculoskeletal health, and cognitive function pre-, intra-, and post-ICU stay. Skills gained during this fellowship
will provide be a better understanding of frailty and muscle-brain crosstalk, via the kynurenine pathway, that
occurs during an ICU stay and how it may influence long-term physical and cognitive health.

Public health relevance
Narrative: Older adults are more prone to experiencing poorer long-term physical, mental, and cognitive health due to age-related frailty, which can become exacerbated during episodes of critical illness that results in admission to an Intensive Care Unit (ICU). Prior reports suggest that the cognitive dysfunction is related to physical health but mechanistic links between skeletal muscle and brain have been under explored. Therefore, the goal of this project is to determine the associations between elevated neurotoxic kynurenines with physical and cognitive in older patients in the ICU and after discharge.